A prospective examination of TAC features as predictors of consequences and alcohol use disorders

PROJECT SUMMARY
Young-adult alcohol misuse is a public health problem causing thousands of assaults, injuries, and deaths
each year. Both college and non-college adults frequently report high drink counts (e.g.,10+ drinks) and
many alcohol-related consequences. Approximately 13% meet criteria for past-year alcohol use disorder
(AUD) and problems associated with AUDs frequently continue into midlife. Although measurement of
drinking is necessary for assessing these risks, concerns have been raised about exclusive reliance on
self-reported drink counts, especially on heavier drinking nights. Our pilot work supports this concern,
showing that over 12 weekend days: 1) 70% of the sample reported blackouts (55% reporting multiple
blackouts), and 2) the rate of blackout was 1 in every 3 drinking days. These and associated impairments
may affect the accuracy of self-reported drinking and lead to underestimation of the links between alcohol
consumption and outcomes (consequences and AUD). To address this concern, we have used objective
watchband-like transdermal alcohol concentration (TAC) biosensors in our studies. TAC assesses alcohol
use in near real-time and records the manner in which alcohol is being consumed through continuous
measurement of alcohol intoxication. TAC features from the rising portion of the curve for each drinking
day – rise rate, peak, and rise duration – capture dynamic aspects of drinking behavior that standard drink
counts do not. Our pilot data provide evidence that TAC features predict consequences and are
associated with baseline AUD. These findings are promising, but they are limited to small samples over
short time spans (1-4 weeks). These short time spans limit generalizability of TAC effect size estimates
and have prevented prospective tests of TAC features as predictors of outcomes that develop over long
time spans (i.e., AUD). The proposed research addresses these gaps using a large-scale measurement
burst design consisting of eight 14-day bursts across two years among 500 young adults (ages 19-22)
who frequently engage in heavy episodic drinking. Aim 1 will examine TAC features as predictors of
alcohol-related consequences, relative to EMA self-reports. Aim 2 will assess AUD using DSM criteria at
baseline, 12, and 24 months and focus on examining the contribution of TAC features, relative to EMA
self-reports, in predicting AUD. The scientific premise of our research is fully supported by the literature
and our past studies. Together, these warrant further study of how well TAC features can predict: 1) event
level alcohol-related consequences, and 2) AUDs. Our approach uses a rigorous longitudinal and
multimodal measurement burst design to address these significant gaps in the field.

Public health relevance
PROJECT NARRATIVE Alcohol misuse is a major public health problem that results in thousands of annual arrests, assaults, injuries, alcohol use disorders and deaths, in both college and non-college young adults. Our past research has shown that wearable alcohol wrist sensors measuring the amount and manner in which alcohol is being consumed improve accuracy when combined with self-reported drink counts to predict consequences in natural settings. The proposed research greatly extends our past work using a multimodal, large-scale study to be the first to establish to what extent alcohol intake assessed by wearable alcohol wrist sensors can predict: 1) acute risk associated with single drinking events and 2) the development of alcohol use disorders.